Effects of Earlier And Higher Vitamin D Supplementation in Extremely Preterm Newborns at 2 Years Of Age

PROJECT SUMMARY
Extremely premature (EP) infants (<28 weeks gestation) often have vitamin D deficiency at birth that worsens
in the first month after birth and may have lasting direct or indirect adverse effects on the developing lungs,
bones, brain, and immune system, contributing to the high rate of chronic lung disease, osteopenia, infections,
and neurodevelopmental impairment in EP infants. “Normal” vitamin D levels have been extrapolated from older
children and adults, and the supplementation regimen & blood levels that result in the best health of EP infants
are unknown, causing wide variation in official recommendations and clinical practice.
This study builds on the ViDES trial (NCT05459298): a KL2-funded, phase IIB, blinded randomized trial
comparing neonatal effects of two vitamin D supplementation regimens in EP infants (400 IU/day after feeds are
established [the most used regimen in the U.S.] vs. 800 IU/day started in the first 96 h after birth [a more common
regimen in Europe]) for the first month after birth. All infants then receive 400 IU/day. Our primary aim for the
proposed R03 research is to test the hypothesis that the earlier and higher dosage regimen will improve
pulmonary mechanics and wheezing at two years with similar, if not better, bone density, cognition, and infection
rates. We also aim to identify vitamin D blood levels associated with the most favorable outcomes in EP infants
and conduct exploratory analyses to assess whether race, ethnicity, sex, or gestational age are effect modifiers.
We will use sophisticated assessments including: a) Liquid Chromatography-Tandem Mass Spectrometry to
assess 25-hydroxyvitamin D and other vitamin D metabolites; b) non-invasive oscillometry to measure pulmonary
mechanics during spontaneous breathing; c) the validated International Study of Asthma and Allergies
questionnaire to assess wheezing; d) quantitative ultrasound to assess bone density by speed of sound
transmission through the tibia. With our large population, NICHD Neonatal Research Network infrastructure, and
high follow-up rate, we expect to assess at least 135 infants at 2 years (accounting for 15% mortality/ withdrawal
of the study and a follow-up of 90%). We will assess the probability of benefit from the earlier, higher dosage
regimen on pulmonary mechanics, wheezing, and bone density in conservative Bayesian analyses (using a
neutral prior).
The success of the ViDES trial to date, the expertise of our team of mentors and investigators (including
Glenville Jones [Queen's University, Kingston Ontario], Anna Marie Hibbs [Case Western], Carol Wagner
[South Carolina] and Matthew Rysavy [UT Heath]), and the commitment and resources of my primary mentor
(Jon Tyson [UT Heath]) to cover cost overruns help to ensure the project's feasibility, execution, and validity.
A better approach to vitamin D could prove to be a simple and inexpensive method to improve the outcomes
of EP infants. Whatever the results, they will advance the understanding of vitamin D in EP infants and how
best to prevent adverse multisystem disorders due to vitamin D deficiency in small preterm infants.

Public health relevance
PROJECT NARRATIVE Premature babies born very early (less than 28 weeks) often lack vitamin D, which can affect their lungs, bones, brain, and immune system, contributing to their problems with chronic lung disease, weak bones, developmental problems, and infections. This study will compare two of the most common ways to give vitamin D during the first month after birth and evaluate the effect on the bones and lungs of most premature infants at two years old. This research will help improve the care of very premature infants by learning how soon after birth to start giving vitamin D, how much to give, and what level in their blood is best.